BMS-984923 Non-Clinical Development to Support Phase 2 Trials

SUMMARY/ABSTRACT
This project seeks to develop a novel disease-modifying compound for AD (AD) by targeting the underlying
mechanism of synapse loss. Synapse loss is tightly correlated with cognitive decline and is triggered initially by
amyloid-β peptide oligomer accumulation. Soluble amyloid-β oligomers bind to Prion Protein, thereby engaging
mGluR5 as a co-receptor, and activating PTK2B (Pyk2) and Fyn kinases to couple with Tau pathology and
synapse loss. Genetic knockout studies in rodents have shown that knockout of mGluR5 prevents disease onset,
and our target sits directly upstream of PTK2B, a GWAS hit in AD. These features provide strong evidence of
mGluR5 as a promising therapeutic target for developing novel Alzheimer’s treatments.
Allyx Therapeutics has obtained an exclusive license for use of BMS-984923 in neurodegenerative diseases
from Bristol Meyers Squibb and Yale University. Preliminary studies demonstrate robust efficacy of this small
molecule treatment in multiple preclinical mouse AD models. Drug treatment recovers synapse density, restores
hippocampal activity, and returns memory performance to normal levels. Pre-clinical development has
characterized a highly drug-like profile allowing for the recent approval of the BMS-984923 commercial IND for
the initiation of first time in human clinical studies. The overall goal is to develop disease-modifying oral drug
effective to slow, halt or partially reverse AD progression both in the MCI state and in mild dementia.

Public health relevance
PUBLIC HEALTH NARRATIVE Today, no conclusive disease-modifying therapies for AD are available. Synapse loss in AD brain has been tightly correlated with symptoms and is triggered initially by amyloid beta peptide accumulation. We have mapped a pathway from amyloid-β oligomers to synapse loss. Central to this pathway is the transmembrane receptor mGluR5, a metabotropic glutamate receptor, which when complexed with cellular prion protein triggers synaptic dysfunction and recruits immune mediators for microglial mediated pruning. We have developed an orally bioavailable small molecule drug which selectively blocks AD dependent damage while preserving normal physiologic signaling through mGluR5. Here, we aim to develop this compound to slow, halt or partially reverse AD progression both in the MCI state and in mild dementia.